Functional Antibody Repertoire Against S. aureus Leukocidins after Invasive Human Infection

PROJECT SUMMARY / ABSTRACT
Staphylococcus aureus is now the most common invasive bacterial pathogen in children in the US, and
antibiotic resistance rates continue to increase. Novel targets and approaches are needed if a safe and
effective S. aureus vaccine is to become a reality. Optimal targets of intervention against S. aureus, a highly
human-specific pathogen, may be identified most effectively by defining the antigens that contribute to invasive
human infections. LukAB, a secreted leukotoxin, is produced by S. aureus in the setting of invasive human
disease and is essential for immune evasion by the pathogen in a variety of models. We have purified a series
of potently neutralizing human monoclonal antibodies (mAbs) targeting LukAB, which have broad neutralizing
capacity, distinct binding sites and mechanisms of activity, and efficacy in a murine model of sepsis. The
overall goals of this proposal are twofold: first, to test the hypothesis that key aspects of the human
anti-leukocidin adaptive response include both mechanisms of toxin neutralization and the function of
non-neutralizing antibodies targeting these toxins; second, to test the hypothesis that a selected
combination of mAbs with distinct functions will most potently inhibit toxin-mediated staphylococcal
immune evasion. Careful validation of the anti-leukocidin antibody response in rigorous models will allow for
the evaluation of human mAbs as candidate agents of intervention against S. aureus. The proposed studies
will define the diversity of the naturally occurring antibody repertoire to S. aureus leukocidins following natural
human infection, given their importance in virulence and promise as targets of intervention. This will be
accomplished by: 1) Characterizing the diversity and functional capacity of naturally occurring human
antibodies targeting the staphylococcal leukocidins following invasive pediatric infection; 2) Elucidating the role
of non-neutralizing antibodies specific to S. aureus leukocidins, including antibody-dependent complement
deposition and phagocytosis; and 3) Determining the critical components of the anti-leukocidin adaptive
response against S. aureus in human blood. We will leverage our existing workflow for the purification and
characterization of neutralizing mAbs from prospectively enrolled children with invasive and non-invasive S.
aureus infections at a major tertiary care children’s hospital. A panel of human mAbs will be created to allow
the investigation of diverse mechanisms of neutralization, cross-toxin activity, and other important functions.
The proposed aims will define, for the first time, the breadth of mechanisms by which the human host response
targets and neutralizes S. aureus leukocidins during invasive human disease. Together these studies address
a critical need for novel anti-S. aureus strategies. This work is designed to produce rationally selected
candidates for anti-staphylococcal interventions based on our knowledge of important antigens expressed
during human disease, obtained from children with S. aureus infections, to be tested for efficacy in humanized
animal models in immediately subsequent work.

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus is now the most common bacterial pathogen causing invasive diseases (e.g., bloodstream infections) in children in the US, and new targets of therapy against this important organism are urgently needed. The overall goal of this proposal is to define key components of the human immune response against an important group of toxins secreted by S. aureus, the leukocidins, known to be produced during invasive disease in children. This will be accomplished by isolating antibodies produced by children with invasive S. aureus disease, determining how they interact with the pathogen and block toxicity, and testing their ability to help the human immune system to target and kill S. aureus.